Dissemination: Communication, Training and Outreach in Support of Enhanced Echinobase

SUMMARY DISSEMINATION
Communication, Training and Outreach in Support of Enhanced Echinobase
Echinobase, a model organism knowledgebase (MOK) for the phylum of Echinodermata, is a web accessible
resource that integrates the vast and diverse genomic and biological data from the multiple species utilized for
echinoderm research. The Dissemination component is one part of a multi component project to maintain and
enhance the function and content of this resource that is essential for the echinoderm research community and
facilitates research productivity. The goal of Disseminate is to support current users, and attract more
Echinobase users by providing a functional, well-maintained, up-to-date destination for data managed using
FAIR principles, that is of interest to a broad community to empower researchers to make further advances,
particularly in understanding gene regulation and gene regulatory network function during development. Future
development efforts and features are guided by community member input and feedback, dialogue with the
Scientific Advisory Board, PIs and discussions with other MOKs. Plans are to actively engage users by
communicating progress and providing workshops for accessing, analyzing, and submitting data to
Echinobase. Scientific papers, talks and poster presentations at conferences such as the Society of
Developmental Biology, and the Developmental Biology of the Sea Urchin and other Marine Invertebrates
(DBSUMI) and virtually through EchinoClub, will present new updates, and aspects of echinoderm genomics to
a wide community. Disseminate will ensure that data is shared with external resources such as NCBI, Ensembl
and UniProt, continue collaborations with AGR and EBI and also enrich links from Echinobase to outside
resources. The ability to disseminate the features relies on communications between components that are
organized by the Admin Team. The past several years have proven a good working relationship between the
curation, computational and technical development teams for communicating ongoing activities and problems
and collaborating on creating Echinobase.